Functional neurovascular coupling in a mouse model of Alzheimer's Disease

Goal of Proposed Research Alzheimer’s disease (AD) is the most common neurodegenerative disease, presenting with progressive and irreversible memory loss and dementia. Although medications and management strategies can temporarily improve symptoms, no cure so far exists. Therefore, there is a high demand for underlying the cause, pathological conditions and behavioral symptoms of AD for advancing possible preventions and treatments. The central goal of the proposed research is to determine functional neurovascular coupling of the dentate gyrus and its underlying neural circuit mechanism in a mouse model of AD.

Public health relevance
Disease, degeneration or traumatic injury of the nervous system are among the greatest public health concerns in the United States and are generally considered irreparable, often causing catastrophic damage to the functional capacity of the individual. The research proposal here aims to study the functional neurovascular coupling in the hippocampal of a mouse model of AD. Importantly, whether the context exploration mitigates the possible declined coupling will be determined. If successful, this supplement will lead to improved understanding of energy homeostasis in AD condition, possibly leading to the development of new drugs for mitigating the declining neurovascular coupling in the AD. The findings will motivate an R01 application to continue the research of neurovascular coupling in AD.